Mechanisms underlying reversal of cardiac aging by urolithin a treatment

PROJECT SUMMARY/ABSTRACT
Aging is one of the greatest risk factors for the development of cardiovascular disease and heart failure.
Mitochondrial dysfunction in the aging heart is thought to be an important contributing factor to the decline in
cardiovascular function with age, including hypertrophy and left ventricular wall thickness, diastolic dysfunction,
and reduced contractility and calcium dynamics that contribute to the increased risk for clinically important
cardiovascular disease. Despite the growing interest in the mitochondrial biology of aging and the clear clinical
and

Public health relevance
NARRATIVE Urolithin A is a natural supplement produced by the gut microbiome in about 50% of adults that has been shown to improve mitochondrial function, reduce inflammation, and improve function in multiple tissues in chronic disease models. This proposal builds on our preliminary data demonstrating that supplementation with urolithin A enhances cardiac function in aged mouse hearts. We propose multiscale assays to identify the mechanisms by which urolithin A improves cardiac function and help determine the potential for urolithin A supplementation to enhance healthy aging.